Toward standardizing perceptual voice quality measures

ABSTRACT Perception of pathological voice quality is centrally important in clinical voice evaluation, but adequately quantifying the sound of a person's voice remains problematic. Data from studies completed during the previous funding period indicate that many difficulties associated with current measures of voice quality derive from the way in which quality is defined and measured. We propose the development of a psychoacoustic model of overall voice quality as an alternative to traditional ratings and acoustic analysis protocols. This psychoacoustic model will specify a set of perceptually-important acoustic parameters that combine to replicate and thereby quantify the overall, integral quality of a voice. We will first determine the minimal set of acoustic parameters required to produce a synthetic copy of any voice, such that listeners judge that the synthetic copy matches the quality of the original voice. This set will constitute a preliminary psychoacoustic model of voice quality. We will then refine and validate this psychoacoustic model by synthesizing copies of natural voices using only these model parameters. To the extent that listeners judge that the natural and synthetic tokens match exactly, the psychoacoustic model will be considered valid. Mismatches will be analyzed to determine what parameters should be added to or subtracted from the model. We will assess the relationship between changes in acoustic values and changes in the extent to which a voice deviates from normal. This will provide an explanatory model specifying how acoustic parameters combine and interact perceptually to determine the location of any voice sample along a continuum from better to worse. Finally, we will investigate the link between perceptually-important acoustic, spectral changes and the associated alterations in glottal configuration. Such knowledge could identify targets for remediation that have the highest likelihood of producing vocal improvement during treatment.

Public health relevance
PROJECT NARRATIVE Measurement of voice quality is a prime concern in management of patients with voice disorders, but problems of reliability and validity persist for existing procedures for gathering such measures. The proposed research will establish a valid, reliable, theoretically-motivated alternative to current systems for measuring voice quality. By using confirmatory methods to establish causal links between acoustic variables and perceived voice quality, the proposed studies will enhance our understanding of the relationship between a voice signal and the perceptual response it evokes, leading to a standardized, perceptually-validated, objective protocol for clinical use. Further, these measures will enable us to generate and test preliminary hypotheses regarding the changes in glottal configuration that cause perceptually-important changes in vocal acoustics, thus providing some of the first experimental evidence linking perception to production. By establishing links among physiology, acoustics, and perception, this research may significantly advance clinical practice. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The overall aims of this proposal are 1) to complete development of a theoretically-motivated measurement protocol for voice quality that enables users to reliably and validly assess the overall, integral quality of a voice; 2) to link measures of voice quality made with this protocol to changes along a better/worse continuum, and to underlying glottal pulse shapes, leading to clinical application; and 3) to complete development of the tools needed to accomplish these goals. Such a quality measurement system is required because, as the speech chain model states, voice exists as a series of events linking a speaker to a listener. For this reason, clinical understanding of any one aspect of voice-physical, acoustic, and/or perceptual- requires knowledge of the other two. For example, changes in vocal fold vibratory patterns or glottal pulse shapes are important to the extent that they produce perceptually meaningful changes in the sound of the voice-an inaudible physical change is not likely to be clinically relevant. Similarly, a change in voice quality means that some change has occurred in the way the voice is produced, whose acoustic result was transmitted to the listener where it ultimately elicited the perceived quality. Because of these linkages among production, acoustics, and perception, we can answer very few basic questions about vocal function without benefit of an adequate model of quality. In other words, much of the meaning of vocal fold function and acoustic measures in the study of voice derives from their ultimate influence on perceived quality, and thus cannot be formally established unless quality is successfully quantified. Our previous research has led to development of a preliminary psychoacoustic model that explains and quantifies quality as a small set of acoustic parameters of known perceptual importance, that combine to reproduce the complete sound of a voice. Based on source-filter theory, this model includes spectral-domain measures of the voice source, the noise-to-harmonics ratio, formant frequencies and bandwidths, F0, amplitude, and their variability over time. This approach links features of the acoustic signal to perceived voice quality in the listener, thus ultimately enabling straightforward use of acoustic measures as indices of vocal quality. The first Specific Aim of this proposal is to complete development of this model by specifying a set of acoustic features that are perceptually necessary and adequate to quantify overall voice quality, and to validate this model by synthesizing copies of natural voice samples using only measured model parameters. To the extent that listeners judge that the natural and synthetic tokens match exactly, the psychoacoustic model will be considered valid. Clinical quality evaluation generally involves assessing the extent to which a voice sample deviates from "normal" (for example, at assessment), or evaluating how much one sample differs from another along a continuum from better to worse (change with treatment), or both (assessing treatment effectiveness). In addition, clinical measures of quality should ideally link quality changes to changes in glottal pulse shapes, as noted above. Application of a quality measurement protocol in clinical settings thus requires the further steps of determining how changes in model parameters relate to changes in quality from better-to-worse and link voice perception to voice production. Such information would facilitate objective comparisons among treatments and patients, would enable meaningful comparisons across individual patients and clinicians in evaluation and documentation of treatment efficacy, and would shed light on the physical origin of the particular quality disorder. In Specific Aim 2 we will determine the relationship between model parameters and the extent to which a voice deviates from normal, and examine how perceptually important changes in quality derive from changes in glottal pulse shape. This will provide an explanatory model specifying not only how acoustic parameters combine and interact perceptually, but also preliminary explanations of the physical changes in laryngeal behavior that produce perceptually-important changes in quality. Such knowledge could identify voice "types" and acoustic or physical targets for remediation that have the highest likelihood of producing vocal improvement during treatment, thus providing clinical relevance to each of the acoustic parameters. Finally, in Specific Aim 3 we will expand and refine our voice synthesizer to incorporate needed features and to increase power, flexibility, and ease of use. In particular, we will add features to model and quantify time-varying aspects of quality. The long term goal of our research continues to be the development of a standardized voice quality evaluation protocol. Development of a psychoacoustic model of voice quality and establishing its clinical relevance will bring this goal within reach.